Leveraging Natural Language Processing for Reverberant Speech Enhancement in Cochlear Implants

ABSTRACT
The overarching goal of this project is to develop algorithms to address the difficulties that cochlear implant
(CI) users experience interpreting speech in reverberant listening environments like churches, auditoriums and
classrooms. Recent research has made progress in this area using time-frequency masking techniques, but
these algorithms are often not robust in changing acoustic environments or are not amenable to real time
processing. Machine learning (ML) and artificial intelligence (AI) techniques are burgeoning in many
applications areas recently, but to date, AI/ML approaches for reverberation in CI users have shown limited
success. Our proposed approach is to investigate several AI/ML speech enhancement methods based on the
natural language processing (NLP) field to essentially recognize speech in reverberation and then clean it. We
will provide final assessment of algorithm performance by using the open-source NIH-supported CCi-MOBILE
CI research platform for its ease and flexibility necessary for developing and prototyping CI signal processing
algorithms. We propose to use phoneme-based recognition and automatic speech recognition (ASR)
approaches to develop and test our reverberation mitigation algorithms. Aim 1 will investigate the real-time
feasibility of exploiting phoneme recognition for ML-based T-F masking in CIs. We will develop a novel
phoneme-based T-F mask estimation algorithm and conduct speech recognition tests with an offline algorithm
mode to compare conventional and phoneme-based T-F masking. This work will determine whether phoneme
knowledge is beneficial for speech enhancement in CIs. Aim 2 will investigate the utility of real-time T-F mask
estimation in CI users. We will implement various T-F mask estimation algorithms to mitigate reverberation
from the literature (including our novel phoneme-based T-F algorithm developed in Aim 1) in real-time in CCi-
MOBILE. In addition to their impact on speech intelligibility, algorithms will be benchmarked against CI
computational limits and tolerable time delays of audiovisual asynchrony. This work will evaluate the
effectiveness of T-F mask estimation algorithms in real-time operational conditions. Aim 3 will investigate
advancing speech intelligibility for CI users via ASR and text-to-speech synthesis (ASR-TTS). We will
investigate various front-end speech enhancement strategies to improve ASR predictions and TTS engines
with generic and familiar synthetic voices. This work will use CCi-MOBILE to evaluate the utility of ASR-TTS
and the effect of speaker familiarity on reverberant speech intelligibility in CI users. Our team brings AI/ML,
hardware, experimental testing and audiology experience that will be needed for successful research. CCi-
CLOUD, a cloud feature of CCI-MOBILE, will be used to facilitate remote and collaborative CI user studies.
Our work is highly innovative and has the potential to instigate a paradigm shift towards AI/ML-driven auditory
protheses that leverage NLP to adapt speech processing strategies to acoustic settings to maximize user
benefits. Demonstrated success will improve the quality of life of CI users.

Public health relevance
PROJECT NARRATIVE While cochlear implants (CIs) provide high levels of speech comprehension in quiet for individuals with moderate to profound hearing loss, speech in quiet scenarios are rarely encountered outside of the home. The presence of noise or reverberation in the listening environment decreases speech comprehension for CI users much more rapidly than for normal hearing listeners. While current commercially-available CIs include noise mitigation algorithms, there is currently is no robust solution available in CI processors to mitigate the effects of reverberation. The proposed research aims to leverage contextual language information from the predictability of speech signals to develop robust reverberation mitigation algorithms for CI processors, thereby improving the ability of CI users to interact in real-world listening environments, with broader relevance to hearing aid systems.